IGF::OT::IGF LINKING CENTERS FOR MEDICARE & MEDICAID SERVICES (CMS) DATA TO NIA-SUPPORTED SURVEYSCONTRACT NUMBER: RFQ # HHS-NIH-NIDA (SSSA)-2015-CSS-22CAN 8469734PROJECT 120919

Linking Centers of Medicare and Medicaid Services (CMS) Data to NIA Supported Surveys